Enhanced Stem Cell Therapy with Rehabilitation Strategies for Peripheral Nerve Regeneration

Project Summary
Over 100,000 peripheral nerve injuries (PNI) including motor vehicle and combat
accidents occur annually in the U.S. and Europe. In addition, PNI accounts for nearly one
fourth of the pediatric nerve damage. Common causes in children include direct trauma
related to birth, motor vehicle accidents, as well as tumor, vascular, and compression
injuries. Approximately $150 billion is spent each year because of nerve injury, with 87%
of these costs due to lost production outside of healthcare system. Most patients are left
with lifelong functional deficits, creating a major personal and societal burden. The
current gold standard is to use a patient's own nerves harvested from one location to treat
nerve defects at injury site. However, the drawbacks are significant including the limited
availability of the donor nerve, size of donor nerve, and scarring and complications
occurring at the surgical sites. Recently, human neural stem cells (hNSCs) have emerged
as a potential treatment for neural recovery. However, there is limited graft survival (5-
20%) immediately following transplantation due to acute inflammatory/immune
response and neurotrophic factor withdrawal in the complex microenvironment. This
subsequently diminishes the therapeutic effectiveness of hNSC therapy. It is crucial to
understand how transplanted hNSCs are influenced by their microenvironmental cues to
sustain their viability and elicit the desired cellular behaviors to enhance nerve repair.
Stem cells interact with their microenvironment through biochemical factors,
matrix proteins, and cell-cell interactions. My research focuses on using regenerative
strategies to biophysical, biochemical, and bioelectrical microenvironment to further
enhance the therapeutic potential and sustain the survival of transplanted hNSCs to
repair nerve defects. Specifically, hNSCs will be electrically stimulated and encapsulated
in silicon nanopore membrane (SNM) for enhanced therapeutic effectiveness and survival.
In addition, physical rehabilitation will be implemented to promote nerve recovery. The
goal of this research is to understand biological pathways related to peripheral nerve
repair through biochemical modulation, and electrical and physical rehabilitation to
enhance the therapeutic potential of hNSCs. By understanding the interplay between
stem cells and various forms of rehabilitation strategies, we can investigate new device
approaches and identify essential pathways that can translate into better neural recovery
and nerve regeneration strategies for PNI in humans.

Public health relevance
Project Narrative This research aims to advance our understanding of biological pathways related to rehabilitation strategies (i.e. electrical modulation and physical exercise) and stem cells, and their combined therapeutic benefits for improving nerve regeneration and functional recovery in animal models with peripheral nerve injury. A better understanding of hNSCs' response to their microenvironment through electrical modulation and physical rehabilitation will provide discoveries and insights on new device approaches and drug candidates for neural recovery and nerve regeneration. These advances will translate into better therapies for patients with peripheral nerve injury.